Leveraging cancer-evolved resistance mechanisms to enhance EZH2 activity in adoptive T cells

Abstract
The clinical landscape of metastatic melanoma has been revolutionized by immune checkpoint blockade
(ICB); however, despite these advancements, the effectiveness of ICB for metastatic melanoma is limited to
approximately half of patients1. The development of acquired resistance, in part through the loss of MHC-I
antigen presentation, leaves most patients to experience disease progression2–5. Recent advancements have
highlighted the use of adoptive cell therapy (ACT) for treatment of ICB resistant melanoma (e.g., CAR T cells)6–
8. However, the solid tumor microenvironment (TME) presents a critical barrier for success of T cell-based
therapies largely due to the direct competition between tumor-infiltrating lymphocytes (TILs) and cancer cells for
metabolic resources, rendering T cells dysfunctional and exhausted9,10. There is an urgent clinical need for the
development of new strategies to engineer adoptive T cells with the ability to sustain function in the harsh solid
TME, particularly if these approaches can be combined with other therapies (e.g., small molecule targeted
therapy) to improve clinical outcomes.
Our group and others have recently reported that TME-induced environmental stress leads to epigenome
remodeling events within TILs, including loss of the histone methyltransferase EZH211. EZH2, a key component
of the Polycomb Repressive Complex 2 (PRC2), induces the repression of gene transcription via methylation of
lysine 27 of Histone H3 (H3K27me3)12. Loss of EZH2, and thereby H3K27me3, in activated T cells leads to
transcriptional reprogramming that results in an exhausted T cell phenotype. Our Preliminary Data suggests that
protecting EZH2 activity in activated T cells circumvents this exhaustion and produces a T cell with durable
activity in the harsh TME. Preliminary Data presented herein, and evidence previously reported by independent
groups, support the premise of our proposal that protection of T cell EZH2 expression and/or activity will create
a more durable and potent ACT. In this innovative proposal, we will rigorously test the hypothesis that preserving
EZH2 function in T cells will enable adoptive T cells to persist and function in the melanoma tumor environment.
To test our hypothesis, we will pursue the following Specific Aims: (1) Demonstrate enhanced EZH2 activity can
protect T cell function in the solid tumor microenvironment, and (2) Engineer EZH2i resistant CAR T cells for
combinatorial treatment of metastatic melanoma.

Public health relevance
Narrative We predict that arming T cells with protected EZH2 function will greatly improve the ability of a T cell to persist in melanoma and other solid tumors. Cancer cells leverage EZH2 for this very purpose and it is likely T cells will benefit similarly. Results from these studies could increase efficacy and durability of adoptive therapy and combinatorial strategies to treat patients with metastatic melanoma and other solid cancers.